TRANSFUSION-TRANSMITTED CMV PREVENTION IN NEONATES

Multiple transfusions which are often necessary as life-saving measures in premature neonates present a 25% risk of cytomegalovirus (CMV) infection. Overt disease, some of which is fatal, occurs in approximately 10% of these high risk infants. Because there has been no practical effective means of prevention or treatment for CMV infection, we propose a definitive system utilizing passive immunization, by taking advantage of an experimental immunoglobulin which now available through our collaboration with the Massachusetts Biologic Laboratories. The CMV immune globulin (CF greater than or equal to 128, IHA greater than or equal to 4000, ELISA greater than or equal to 4000) has been prepared from normal donor plasma, selected on the basis of ELISA tests for high titers of antibody to DMV. It has been formulated as an intravenous product (CMVIG-IV) so that large amounts of antibody can be easily infused. The expectation of clinical success is based on three observations: 1) studies in premature neonates at high risk of transfusion-acquired CMV infection have shown that neonates born to mothers with antibody to CMV have a significantly lower risk of CMV associated disease and mortality, 2) animal studies support the concept that exogenous CMV antibody attenuates CMV disease, 3) recent studies in bone marrow transplant patients given intramuscular cytomegalovirus immune globulin (Massachusetts Biologic Laboratories) have shown that this preparation may prevent CMV infection. For efficiency of study design all neonates at high risk for CMV disease will be randomized in a double blind, controlled trial to receive CMVIG or placebo (1% human serum albumin). Sera from mother - infant pairs and all blood transfused will be stored and analyzed for CMV antibody. Infants will be followed with serial urine cultures to determine the risk of CMV disease. The protective effect of CMVIG and maternal antibody, and the risk of CMV antibody positive blood will all be assessed in relation to morbidity and mortality form CMV disease. Infants will be followed for up to 12 weeks following discharge. We expect the CMVIG-IV to accomplish at least a 50% reduction in CMV infections; in order to demonstrate this with confidence (Alpha=.05, Beta=0.8), we propose to study at least 650 high risk infants. If CMVIG-IV can be shown to be of benefit in this setting, its use may be extended to many other recipients of blood products.